Purchase of an Image-Guided Small-Animal Irradiator

Project Summary/Abstract
Washington University in St. Louis has a rich tradition of radiation research and is a world leader in the field of
radiation oncology for clinical care, as well as physics and biological research. Over the past twenty years, much
emphasis has been placed on the development of instrumentation for the non-invasive imaging of biological
processes in small animals, thereby providing investigators with a better understanding of the biology and the
potential of therapeutic interventions in preclinical models. In this regard, Washington University is a recognized
leader, with outstanding programs and instrumentation for preclinical magnetic resonance, nuclear, and optical
imaging. Preclinical photon irradiators that can deliver radiation to precise anatomical locations in small animals
are an important component of these research efforts. We currently have an XStrahl small animal radiation
research platform (SARRP) irradiator, however, it is nearing the end its useful lifetime and the technology is
outdated. We therefore request funds to purchase a new, state-of-the-art Precision X-Ray SmART+ Biological
Irradiator for small animal radiation delivery. We believe this irradiator is superior to the latest irradiator produced
by Xstrahl. The state-of-the-art SmART+, is an image-guided, isocentric (360°rotation, with arc therapy
capability), self-shielded research irradiator with integrated safety interlock system. It combines a high resolution
(100 µm) cone-beam CT imaging system and a high-dose rate (up to approximately 6.5 Gy/min) therapeutic X-
ray source into a single integrated, computer-controlled platform. It comes standard with a 4500W generator and
has the highest degree of targeting accuracy 0.05mm about the isocenter. Research projects for seven major
users with NIH funding and a critical need for the SmART+ are described, along with two minor users. The PI
has managed the current small animal irradiator for the past eight years and has of expertise in preclinical
radiation and cancer biology research. He has assembled a strong team to oversee operations and QA of the
instrument. In addition, Washington University has made a significant institutional commitment to ensure the
successful use of the device after its installation. The irradiator will allow investigators to study basic questions
regarding radiation research in an in vivo, preclinical model that will eventually lead to new paradigms in the way
we treat disease in the clinical setting.

Public health relevance
The goal of this grant is to obtain funding to purchase a state-of-the-art image-guided small-animal irradiation device (Precision X-Rad Small Animal Radiation Therapy (SmART)+ Biological Irradiator (Precision X-Ray, Madison, CT) that will allow delivery of x-ray irradiation in a precise and accurate manner to specific tissues of small animals. This will replace our current small-animal irradiator which is nearing the end of its useful lifetime. This device is needed to study radiation biology and therapy in a clinically relevant manner in small animals and is essential to continue the highly productive, NIH-funded research projects that make up our User group.